PRONE REFLUX SLING EVALUATION AS TREATMENT FOR GASTROESOPHAGEAL REFLUX

This protocol quantitates reflex over 20-24 hrs in baseline free-form conditions and in the reflux sling testing the hypothesis that the prone reflux sling is an effective therapy for less than one-half of infants with pathological GER.